Single Molecule Glycosaminoglycan Sequencing using Lysosomal Enzymes

Glycosaminoglycans (GAG) are a family of large, linear, sulfated polysaccharides produced in mammals and
other organisms. GAGs play diverse roles in tissue development/growth, inflammation, blood coagulation, viral
infection, and amyloid plaque formation. As a result, GAGs have been used as biomarkers for many diseases.
They are also the most widely used anticoagulant. Because of their biological activities, interest in structure-
activity relationships of GAGs has always been high. However, due to their size, complexity, and heterogeneity,
the analysis of GAG structures using conventional ensemble techniques is challenging. There is currently no
method to sequence these important polysaccharides. We have been exploring single-molecule techniques for
determining GAG structures for several years. Although work from us and other groups demonstrate that solid-
state and protein nanopores can obtain some structural information on GAG polysaccharides, full sequencing of
GAG by nanopore has not been realized because of a lack of translocation speed control. In this proposal, we
want to develop a new single-molecule GAG sequencing method using fluorophore-labeled lysosomal GAG
degradation enzymes. Our idea is inspired by fluorescence-based single molecule sequencing techniques for
other biopolymers. These techniques utilize processive enzymes whose action on the polymer produces fluo-
rescent signals that can be used to infer the sequence. We think lysosomal GAG degradation enzymes are
perfect for this method. In particular, these enzymes processively degrade GAG from the non-reducing end (NRE)
and each enzyme recognizes a specific feature of the NRE. As a result, the degradation of GAG proceeds
through a set of enzymatic steps determined by the GAG sequence. This means the GAG sequence can be
determined by the order in which enzymes bind the polymer. In this proposal, we want to develop such a se-
quencing method by producing a set of lysosomal GAG degradation enzymes each with a unique fluorescent
signature for identification. These enzymes will be used to degrade immobilized GAG chains while the unique
fluorescence of each enzyme can be used to determine these enzymes’ binding order. This information can then
be used to infer the GAG sequence. Because such a method requires no homogeneous samples, can sequence
longer GAG polymers, and can provide high-resolution information, we think its realization will be a dramatic
improvement over existing techniques. In particular, we want to complete the following two aims: 1) Design and
produce fluorophore-labeled GAG degradation enzymes and use TIRFM to characterize the fluorescent signa-
ture these enzymes produce when binding the correct immobilized substrates. 2) We will prepare a library of
structurally defined GAG ligands and use the data obtained from aim 1 to determine their structures using these
fluorophores labeled enzymes. Completing these aims will provide the crucial foundation for developing a gen-
eral method for sequencing GAGs.

Public health relevance
Project Narrative Work proposed here will allow single molecule sequencing of glycosaminoglycan polysaccharides using TIRFM or ZMW for the first time. Glycosaminoglycans have important pharmacological properties and are modulators of critical biological phenomena such as tissue development/regeneration and inflammation. Determination of their structures will allow better understanding of how organisms control these physiological processes through glycosaminoglycans.